Mitochondrial Metabolic Regulation of GABAergic Interneurons

Project Summary/Abstract
Primary Mitochondrial Diseases (PMDs) result from intrinsic dysfunction of mitochondria and have a
prevalence of 1 in 5,000. Although over half experience neurologic symptoms, PMDs are heterogeneous both
genetically and phenotypically. Given the disease heterogeneity, metabolic pathways common to multiple
forms of PMD are appealing therapeutic targets. However, the full extent of mitochondrial metabolism in
neurons is incompletely understood as in addition to generating energy in the form of ATP through the electron
transport chain (ETC), mitochondria also generate metabolites through the TCA cycle and reactive oxidation
species, any of which may contribute to neuronal function. The foundation of this proposal is based on
preliminary studies indicating that the mitochondrial TCA cycle plays a critical role in GABAergic inhibitory
interneurons which are essential for regulating excitatory neuronal circuits. The focus of the proposal is to test
whether the ETC is required for inhibitory interneuron survival or GABA metabolism. The two aims will: (1) use
an in vitro iPSC-derived inhibitory interneuron system to evaluate acute manipulation of mitochondria; and (2)
use mice lacking mitochondrial function in hippocampal GABAergic interneurons to establish the effects of
chronic mitochondrial impairment. The scientific purpose of this proposal is to begin defining the effects of
mitochondrial metabolism in GABAergic hippocampal neurons, with the vision of expanding the tools and
measurements in GABAergic neurons including those outside the hippocampus, and eventually translate
findings by therapeutically targeting metabolism to promote neuronal health in mitochondrial disease. The
proposal is a five-year physician-scientist development program for the candidate who is an Assistant
Professor of Pediatrics at Northwestern University, with 75% protected time for research, independent
laboratory space and start-up funding. In addition, his clinical time at Lurie Children’s is dedicated to managing
children with mitochondrial disease in both the outpatient and inpatient critical care setting. He is committed to
a career in translational mitochondrial metabolism research focused on neurologic symptoms and is strongly
supported by his Department of Pediatrics, Section of Child Neurology and his mentorship team. The
candidate will build on his prior experience in neuroscience by learning advanced techniques in mitochondrial
metabolism research under the guidance of his primary mentor, Dr. Navdeep Chandel. Additionally, his co-
Mentor, Dr. Mustafa Sahin at Boston Children’s and Harvard, will provide project- and career-level guidance as
an experienced translational researcher and child neurologist. Together, the proposed experiments,
collaborations with experts, advice from consultants and formal didactics will provide the skills and experience
for his transition to independence as a physician-scientist with unique expertise studying mitochondrial
metabolism in neurons, with the long term goal of translating the findings into treatments for PMD.

Public health relevance
Project Narrative Mitochondria regulate metabolism, the process that changes food to energy and if people have abnormal or missing copies of the genes required for mitochondrial function they will develop primary mitochondrial disease for which there are neither cures nor treatments. Many patients with mitochondrial disease have neurologic symptoms, so to understand how mitochondrial dysfunction causes neurologic problems, this proposal studies mitochondrial metabolism in neurons. Successful completion of the proposed studies would result in advancing both the understanding and methods for studying mitochondrial metabolism in the brain, with the goal of translating these findings into treatments for patients with mitochondrial diseases.